Research Education Component

REVISED PROJECT SUMMARY – RESEARCH EDUCATION COMPONENT (REC) The Mayo ADRC Research Education Component (REC) will offer a comprehensive training program to equip the next generation of clinicians and investigators with the necessary skills to attack the complexities of Alzheimer’s Disease and related dementias (AD/ADRD). The multidisciplinary expertise of the faculty of the Mayo ADRC REC encompasses all facets of AD/ADRD research, including clinical and basic science, neuropsychologic, neuroimaging, genomics, biofluid, neuropathologic, digital, and bioinformatics components. The REC faculty have expertise not only in Alzheimer’s disease, but in other dementias encompassed by the ADRD definition, such as Lewy body dementia/Lewy body disease, frontotemporal lobar degenertion/frontotemporal dementia, and cerebrovascular disease/vascular dementia, as well as multi-etiology dementia resulting from combinations of these. Training will be provided via lectures and courses, group discussions, seminars and workshops, face-to-face interactions with Clinical Core research participants, as well as through laboratory work and experiences which leverage biofluids, genetic data, and tissue specimens from ADRC Cores. In collaboration with the RECs of Wisconsin, Massachusetts, and UCSF ADRCs, we will offer our REC scholars career development opportunities that include site visits, seminars, and networking opportunities